DIAGNOSTIC USE OF ENALAPRIL IN RENOVASCULAR HYPERTENSION

This project is designed to test the hypothesis that the blood pressure and renin responses to intravenous Enalapril constitute a highly sensitive and specific test for renovascular hypertension, when this converting enzyme inhibitor is administered as part of a standardized screen.